PAS proteins: Study and application of signaling mechanisms

ABSTRACT
For cells to detect and respond to changing environmental conditions within and around them, they rely on
proteins to sense these changes and initiate appropriate biological responses. Several classes of ligand-
regulated protein/protein interaction domains participate in these processes, making it important to have
mechanistic insights into their signaling processes to understand both normal function and dysfunction in
disease. Additionally, the ability to switch such protein/protein interactions by small molecules has made these
domains particularly useful for therapeutic and biotechnology applications. Here we focus on obtaining such
mechanistic information for proteins with PAS (Period-ARNT-Singleminded) domains, found in tens of
thousands of proteins throughout all three kingdoms of life, where they control the activity of over 20 enzymatic
and non-enzymatic effector domains. These processes are regulated by different stimuli in different members
of the family, harnessing changes in the occupancy or configuration of bound cofactors to “switch” activity on
and off. Some aspects of these triggers are understood in some PAS domains, such as in the subset known
as LOV (Light-Oxygen-Voltage) photosensory domains, where blue light illumination drives the specific
photochemical formation of protein/flavin adducts which allosterically controls protein conformation around the
chromophore. Despite the need to understand these signaling processes for fundamental and applied
reasons, several knowledge gaps remain limiting our ability to do so. To address these limitations, we propose
a combination of structural, biophysical, and biochemical studies to tackle outstanding issues in the field,
probing topics like the structural and dynamic changes associated with activation, the generality of signaling
processes among related receptors, and correlations between in vitro and cellular activities. We will do so by a
pursuing a strategy based on comparative studies across a group of PAS-containing proteins, including ones
newly-identified by computational or experimental methods as likely to have new ligand specificities and
regulatory modes. We anticipate that the findings of the proposed research will answer long-standing
questions in several areas of protein allostery and biological control, while generating tools to answer pursue
new topics in cellular and in vitro biochemistry.

Public health relevance
RELEVANCE PAS (Period-ARNT-Sim) domains are a widespread group of ligand-regulated protein/protein interaction domains used by organisms to sense and respond to changes in their environment. Using biochemical and structural biology approaches, we are studying mechanistic aspects of this sensing process to uncover how these domains can respond to a wide range of input stimuli and control diverse effectors. Common structural features of these systems make such parallel studies particularly powerful to give insights into a diverse range of biological responses, as well as develop new optogenetic and chemically-controlled tools for biomedical researchers to control cellular function.